Administrative Core

The CePCHe Administrative Core (AC) will consist of 5 components: (1) administration and finances, (2) monitoring and evaluation, (3) External Advisory Committee (EAC), (4) Internal Advisory Committee (IAC), and (5) training and Outreach/In-Reach. The AC will provide an independent administrative structure to support Research Project Leaders (RPLs), and future investigators, promoting a streamlined administrative process, reducing redundancies, costs, and facilitating access to comprehensive Core services. An independent evaluation group will monitor the progress of the CePCHe leadership, the RPLs, pipeline investigators, pilot projects and mentors, and will report findings to the PIs,
IAC and the EAC. This systematic assessment since year 1 will permit monitor the milestones related to RPLs success in completing their proposed research and transitioning to R01-level funding within three years of the start date of this award. This Core will engage RPLs with top scientists from across the country (EAC), who, along with the IAC will work collaboratively to review the quality and progress of the RPLs. Specific aims of the AC include: (1) Provide organizational leadership and administrative structure for the successful completion of the proposed CePCHe program goals, leading to a Phase II COBRE, (2) Effectively mentor early-career faculty in conducting cancer research, preparing competitive research grant applications, and promoting independent funding, (3) Conduct a sustainable long-term faculty development training program for the RPLs program and pilot projects training for cancer research, with a special emphasis on identifying and growing additional junior investigators with the capacity and commitment to successfully conduct high-quality research, using CePCHe resources, including the Bioinformatics and Biostatistics Core (BBC) services and its data repository, to support their emergence as scientifically independent, R-level funded investigators and (3) Pursue innovative initiatives that support the recruitment and career development of outstanding investigators who are well positioned to respond to funding opportunities that span the spectrum of cancer research. The creation of CePCHe will increase the portfolio of faculty invested in cancer research and grow the
research infrastructure with the ultimate goal of decreasing cancer burden and improving
health outcomes.